Auditory perceptual processing in the primate superior colliculus

PROJECT SUMMARY/ABSTRACT
Auditory perception and communication, in particular in natural settings, involves the transformation of noisy,
ambiguous, or uncertain auditory cues into categorical auditory percepts. Contemporary models of hearing
suggest that this process can be conceptualized computationally in terms of decision-making under uncertainty.
By this view, the perception of an acoustic stimulus involves a sequence of computational steps, whereby the
external acoustic input is transformed into an internal decision variable, which, in turn, is transformed into an
auditory percept by way of a comparison to a decision criterion. Despite the fundamental nature of this process
to contemporary models of hearing, however, relatively little is known about the neural mechanisms that support
it in the primate brain. That is, while previous studies have identified brain areas involved in computing decision
variables for auditory perception, very little is known about where or how in the primate brain the relevant decision
criteria are established. The broad goal of the work proposed here is to fill this knowledge gap and determine
the mechanisms in the primate brain that support decision criteria for auditory perception. The proposed research
is focused on the primate superior colliculus (SC), a midbrain sensorimotor structure that receives extensive
auditory input and has been shown to play an important role in decision criteria for visual perception. A series of
experiments are proposed in which novel and innovative psychophysical techniques that provide rigorous
experimental control over decision criteria are combined with neural recordings and causal manipulations of
brain activity in a nonhuman primate model of hearing. The first aim of these experiments is to determine the
role of the SC in decision criteria for spatial perception, whereas the second aim is to determine the role of the
SC in decision criteria for nonspatial perception. Taken together, therefore, the results will paint a comprehensive
picture of the SC's role in decision criteria for auditory perception (i.e., in different decision-making contexts
involving different acoustic stimuli) and provide fundamental insights into the brain bases of normal hearing in
healthy primates, setting the stage for future studies of disordered hearing in the primate brain. As such, the
proposed work is directly in line with NIDCD's mission and strategic plan. The PI of this fellowship application is
a Postdoctoral Associate at the State University of New York College of Optometry, where the work will be
conducted. A sponsorship team consisting of world-renowned experts on the role of the primate SC in higher-
order perceptual and cognitive functions and the neural mechanisms of auditory perception and auditory
perceptual decision-making has been assembled to provide the applicant with research training on a variety of
topics relevant to nonhuman primate auditory research. This training, together with additional, targeted training
focused on the applicant's career development, will prepare the applicant for the transition to research
independence and a productive research career studying the neural mechanisms of auditory perception.

Public health relevance
PROJECT NARRATIVE This is a basic research proposal focused on the neural mechanisms of auditory perception. The overarching goal is to determine the role of the midbrain superior colliculus in a particularly important computational process - the setting of decision criteria - that lies at the heart of most models of auditory perception and communication but about which very little is known in terms of its instantiation in the primate brain. The results, therefore, will provide fundamental insights into the neural mechanisms of auditory perception and communication that, in the long term, may help to inform assays, treatments, or technologies focused on auditory perceptual and communication disorders.